IGF::OT::IGF Website Communications Services for the National Cancer Institute, Division of Cancer Control and Populations Sciences

The provider must conduct a heuristic evaluation (expert review) of the website and two rounds of usability evaluations. The usability evaluations are to be conducted with people representing current and potential grantee researchers, advocate/stakeholders, research staff on DCP-funded network projects, and NCI, NIH, and DHHS staff. The first round of testing will provide critical information to construct a new organization/order for the website, which will be tested in the second round. A final report should include suggested information architecture and other evaluation findings .